EPIGENETIC REGULATION OF THE ESTABLISHMENT OF AN SV40 INFECTION

DNA viruses such as Simian Virus 40 (SV40) exploit cellular processes to control their own life cycle during an infection. In the proposed studies, we are using SV40 as a model to study the selective activation of gene expression in a chromatin environment. We will determine the role of nucleosome location and associated histone modifications present in the infecting virus on the infection-mediated remodeling of chromatin structure required for activating early SV40 genes while maintaining repression of the late genes. These studies are based upon the hypothesis that epigenetic information encoded into the chromatin of virions controls the chromatin remodeling resulting in the initiation of early transcription and repression of late transcription. The specific aims of this proposal are (1) to characterize the epigenetic changes occurring during a typical wild-type SV40 infection leading to the initiation of early transcription and (2) to characterize the initiation of infection and early transcription in epigenetically dysregulated SV40. The location of nucleosomes containing specific histone modifications in SV40 minichromosomes obtained from wild-type and epigenetically dysregulated virus early in infection and in uncoating intermediates from wild-type virus will be determined using ChIP-Seq. Our proposed studies will inform us about events leading to initiation of infection such as: which nucleosomes change position, which histone modifications either decrease or increase during the initial stages of infection, when the changes occur, and the extent to which they depend upon active transcription. Analyzing SV40 chromatin that is transcriptionally poised, we will identify the chromatin elements responsible for repressing late transcription and whether specific nucleosome positioning or histone modifications are necessary at sites of active molecular biology such as the splice sites or the termination of transcription. The work is innovative because it will be the first analysis of the chromatin changes occurring during infection and will be the first analysis in which the location of nucleosomes and their histone modifications will be characterized in chromatin containing RNAPII during the activation of transcription. The studies are significant because they will lead to a better understanding of how nucleosome positioning is regulated by the presence of histone modifications. Additionally, our results will serve as a model for a number of related viruses that are significant human pathogens.

Public health relevance
Simian Virus 40 (SV40) has served as an excellent model system to study regulation of eukaryotic biological processes, as well as a model for a number of related human pathogenic viruses. The proposed studies will be the first to investigate the role of epigenetics in directing the establishment of an infection by a virus. Results from our studies will lead to a better understanding of the regulatory role of epigenetics during the initiation of infection, which can be used in the discovery and development of anti-viral therapeutic agents.